Renewal of "Taming Fluorine: Metal-Organic Frameworks for the Heterogeneous Delivery of Fluorinated Building Blocks"

Project Summary
The preparation of complex organic molecules is vital to the development of next-generation therapeutics.
However, the synthesis of molecules bearing certain fluorinated and chlorinated functional groups, such as
fluoroalkenes, remains challenging. A major barrier to installing these motifs within complex molecules is that
many fluorinated and chlorinated building blocks are gases at room temperatures, which complicates high-
throughput reaction optimization. In a similar vein, the signaling molecules hydrogen sulfide, nitric oxide, and
carbon monoxide, possess therapeutic potential that is difficult to unlock due to their gaseous nature. Molecular
donors for these molecules often result in the co-generation of toxic byproducts upon gasotransmitter release.
We propose an interdisciplinary solution to these and other challenges relevant to medicinal chemistry: the use
of porous materials, such as metal-organic frameworks (MOFs) and porous organic polymers (POPs).
Supported by NIGMS, we have achieved several breakthroughs related to the synthesis and therapeutic
delivery of bioactive molecules. First, we demonstrated the first example of fluorinated gas storage within MOFs,
enabling their safe handling as solid reagents to streamline reaction development (publication in Science).
Second, in a similar vein, we have shown that MOFs can be used to safely deliver hydrogen sulfide for the
treatment of ischemia-reperfusion injury, which can occur during a heart attack or stroke. We have developed
MOF-based catalysts for several industrially important reactions, including amide bond formation and halogen
exchange. We have also employed electroactive molecules to achieve the selective electroreduction of
(hetero)aryl halides without precious metal catalysts. We have also developed several methods for the synthesis
of porous materials, including high-concentration solvothermal, mechanochemical, and ionothermal approaches.
In the next research period, we will pursue three interconnected projects. First, we will employ our gas-
releasing MOFs to develop several methods for the installation of vinyl fluorides and chlorides, as they are stable
bioisosteres for ubiquitous amides in drug-like molecules. To achieve this goal, transition metal catalysis,
electrosynthesis, and photoredox catalysis will be employed; the latter will require the development of new MOFs
for gas storage that do not strongly absorb visible light. We will also develop novel methods for chemical ligation
and stapling of peptides. We will also continue to add gases to our growing library of materials, further expanding
the scope of synthetic transformations we can develop. Second, we will move beyond gas storage through weak
non-covalent interactions to slow down gas release under ambient conditions and achieve stimuli-responsive
gas release. We will demonstrate this concept using hydrogen sulfide delivery from MOFs before extending it to
other biomedically relevant gases. Last, we will leverage the unique properties of isolated metal-halide sites in
MOFs to design new catalysts for nucleophilic aromatic substitution and C-H functionalization reactions,
leveraging confinement effects to tune reaction selectivity.

Public health relevance
Project Narrative The synthesis of complex organic molecules, especially those containing the elements fluorine and chlorine, is demanding yet vital to the preparation of next-generation therapeutics. Some of the associated difficulties including safely handling gaseous reagents and therapeutics, developing site selective methods for fluorine and chlorine incorporation, and unlocking new synthetic transformations using sustainably derived catalysts and reagents. Herein, we propose a multidisciplinary approach to address these challenges: the use of organic and organic-inorganic hybrid materials to safely handle gases as solids and to develop recyclable, heterogeneous catalysts with unique reactivity patterns.